C. elegans models of metabolism in health and disease

Metabolism lies at the heart of most if not all biological processes to generate biomass during
development and in wound healing, to generate energy to support cellular and organismal processes,
and to detoxify exogenous and endogenous toxic compounds. We will study metabolic perturbations
using gene mutants and metabolite supplementations on physiological and molecular phenotypes in
the nematode C. elegans and examine the effect of bacterial diet on these phenotypes. We will focus
on perturbations associated with inborn errors of metabolism (IEMs), which are human metabolic
disorders that are caused by mutations (usually recessive) in metabolic enzymes and transporters. This
work will shed light on the basic mechanisms of how an animal responds to different metabolic
perturbations and how environmental factors such as diet and microbiota modulate them. These studies
may further provide hypotheses relevant for studies in larger eukaryotes, including humans.

Public health relevance
In this project, we will use both gene- and metabolite-centered approaches to study metabolic perturbations in C. elegans with a focus on homologs of genes involved in inborn errors of metabolism in humans. We will combine computational and experimental methods to, broadly and deeply, determine how changes in genotype, nutrition, and the microbiota influence such perturbations.